Biomedical Engineering Training Program

The Biomedical Engineering Doctoral training program at Johns Hopkins University trains
talented students from engineering and other quantitative sciences for careers in biological and
medical research. Our program is based on more than 50 years of educational experience in
Biomedical Engineering, and a collaborative research environment made possible by our strong
presence in both the engineering and medical schools of Johns Hopkins. The program is
interdisciplinary and interdepartmental in nature. Program faculty are drawn from a wide range
of departments. This includes, but is not limited to, the departments of Biomedical Engineering,
Neuroscience, Otolaryngology-Head and Neck Surgery, and Radiology in the School of
Medicine, and the departments of Applied Mathematics and Statistics, Chemical/Biomolecular
Engineering, Electrical and Computer Engineering, Material Science and Engineering, and
Mechanical Engineering in the Whiting School of Engineering. The Program faculty are
engineers, applied mathematicians, neuroscientists, physiologists, physicians, cell biologists,
and molecular biologists with both experimental and theoretical/ computational research
programs. Our sponsored research base remains strong with funding from diverse sources.
Students are drawn mainly from the top engineering programs in the United States. This highly
competitive national pool has allowed us to maintain very high standards of selectivity. In the
past two years, we have significantly increased enrollment of under-represented minority
students. The signature of our educational program is our commitment to provide outstanding
training in both biology and engineering. Our students have the option of learning biology and
physiology alongside medical students in their first year, and engineering and advanced
mathematics in their second year and beyond. Our program is unique in that our students have
the freedom to choose a mentor from any laboratory in the university. This philosophy has
yielded exceptionally productive students who have gone on to become some of the pillars of
biomedical engineering research and innovation in the United States. We enroll about 25
training-grant-eligible students per year, and are requesting 12 training slots. The mean duration
of the program is 5.98 years and median is 5.70 years. Over the past 5 years, the median GPA
of training grant eligible students in our program is 3.83.

Public health relevance
A program is being developed at Johns Hopkins University to support and train graduate students with educational and research interests in the field of Biomedical Engineering. The program trains talented students from engineering and quantitative sciences for careers in biological and medical research.